XAS ELECTRONIC AND GEOMETRIC STRUCTURE STUDIES ON CU CONTAINING METALLOPROTEINS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We propose to extend our previous studies on copper sites in biology, using a combination of S K-, Cu L-, and Cu K-edge and EXAFS spectroscopies, to define the electronic and geometric structure of Cu-containing proteins involved in electron transfer, O2 activation, N2O reduction and cofactor biogenesis. We plan to study H-bonding mutants of blue-copper proteins to evaluate the changes in electronic structure and its effect on the ET properties of BC proteins. A Cu K-edge EXAFS study will be performed on the reduced form of CuA at different pH’s to investigate the effect of pH on the ET and proton-pumping properties of the site. We also plan to study model complexes of mononuclear, binuclear, and multinuclear Cu and Heme-Cu containing proteins that are involved in O2 binding, transport and activation to understand mechanistic pathways of O2 interaction and activation. The model study will be extended and correlated to relevant protein systems to shed light on structure/function correlation of O2 binding and activation by the unique protein active sites.